Defining circuit mechanisms for the regulation of somatosensory feedback

PROJECT SUMMARY
Sensory feedback is critical for reporting the state of the body and how it interacts with the world. Yet the
incessant transmission of all sensory stimuli that impinge upon the body would be debilitating. Rather, sensory
signals must be regulated dynamically to attenuate the disruptive and facilitate the salient. The dorsal column
nuclei complex, located in the brainstem, represents the major conduit of somatosensory information from the
periphery to supraspinal targets. The cuneate nucleus receives and processes sensory signals from the upper
body, conveying the resulting information to the sensorimotor cortex via projections to the thalamus, including
tactile signals from the hand that are especially critical for the effective execution of dexterous behaviors. The
recent identification of a ‘shell’ of local inhibitory neurons in the brainstem that can modulate the transmission of
tactile signals in the cuneate points to circuit mechanisms that might be used to dynamically regulate
somatosensory feedback at its first synapse in the brain. Selective manipulation of these inhibitory circuits can
suppress or enhance the transmission of tactile information, affecting dexterous behaviors. Moreover, these
circuits are subject to top-down control by descending cortical pathways, suggesting that higher-order
sensorimotor regions regulate the sensory signals they receive. Yet several key questions remain unaddressed.
Do these same mechanisms for regulating tactile feedback from the hand apply to cutaneous signals more
generally, and do they generalize to other somatosensory modalities like proprioception? How do these
brainstem circuits and their descending inputs function in behaving animals that require dynamic and
bidirectional adjustment of sensory transmission? Based on preliminary evidence, the central hypotheses of this
proposal are that: a) similar regulatory mechanisms exist in parallel for somatosensory signals generated across
the body; and b) distinct cortical and subcortical pathways can attenuate or amplify the transmission of these
signals to match behavioral needs. Aim 1 leverages molecular-genetic, anatomical, and electrophysiological
approaches in mice to determine whether local inhibitory motifs are repeated in parallel to regulate feedback
across the body and across somatosensory modalities, and whether molecular diversity within these inhibitory
populations is indicative of distinct functions. Aim 2 uses recording and optogenetic perturbation approaches to
establish how these brainstem inhibitory circuits and their top-down cortical inputs operate during behavior, for
example when self-generated feedback needs to be attenuated. Aim 3 sets out to determine whether a newly
identified top-down projection from the central amygdala to cuneate circuits can disinhibit somatosensory
transmission, potentially as a means to augment sensitivity and enhance sensory vigilance. By defining local
and long-distance circuit mechanisms that regulate sensory signals from the body as they first enter the brain,
this work will provide insight into how the nervous system adjusts sensory transmission to match behavioral
context and clarify how circuit dysfunction can lead to pathological changes in sensory sensitivity.

Public health relevance
PROJECT NARRATIVE When considering how essential sensory information like touch is for discerning the state of the body, it becomes clear how either a deficiency or excess in feedback signaling can be disruptive or debilitating. This proposal aims to define how somatosensory feedback is regulated as it first enters the brain and how top-down pathways adjust sensory levels to match the behavioral context. Insight into how neural circuits attenuate or amplify signals from the body will enable improved diagnosis of somatosensory disorders and lay the foundation for targeted therapeutic interventions.